Center for Quantitative Biology Administrative Core

PROJECT SUMMARY
A responsive and proactive Research Administration and Mentoring Core is critical to the successful operation
of any large and complex research program, center, or institute. The overall goal of the Research Administration
and Mentoring Core is to provide leadership and general administration related to all aspects of the Center for
Quantitative Biology (CQB) COBRE. The central responsibilities of the Research Administration and Mentoring
Core are to oversee the mentoring and development of junior COBRE investigators (Aim 1). The Research
Administration and Mentoring Core will also be responsive and proactive to the needs of the CQB - COBRE by
providing administrative, organizational, grant preparation, communication, and financial management support
to COBRE leadership, project leaders, newly recruited faculty, mentors, and cores (Aim 2). This Core will also
be responsible for managing all project and core resources, and will ensure compliance with all governmental
and specific NIH regulations and requirements, including timely communication and consultation with project
officers (Aim 3). Finally, the Core will be responsible for convening all meetings, including monthly meetings of
the internal advisory committee (IAC) and annual in-person meetings of the external advisory committee (EAC).

Public health relevance
PROJECT NARRATIVE The Research Administration and Mentoring Core will provide support for the Center for Quantitative Biology so that COBRE leadership, core directors, project leaders, and mentors can work together to efficiently accomplish the aims of building this Center. Since individual cells are the fundamental building blocks of our bodies, accomplishing the goals of this Center will provide insight into the pathobiology of disease at the individual cell level when their inherent molecular programs go awry.